GnRH Signaling Mechanisms in the Pituitary Gonadotrope

DESCRIPTION (provided by applicant): Activation of the gonadotropin-releasing hormone (GnRH) receptor initiates a number of complex signaling cascades in pituitary gonadotropes. The rhythmic stimulation of gonadotropes by pulsatile GnRH underlies the differential control of luteinizing hormone and follicle-stimulating hormone production, and ultimately the control of reproduction. GnRH receptor signaling cascades regulate gonadotropin secretion, gene transcription and cell differentiation. We have shown that GnRH regulates protein synthesis and activates the unfolded protein response (UPR), a protective response to modulate stressful demands of protein synthesis. The UPR also activated by inflammatory and metabolic stress signals. The regulatory schemes utilized by the GnRH receptor are essential to maintain cell homeostasis and sensitivity to recurring GnRH pulses. To maintain pulse sensitivity and hormone synthesis, gonadotropes must resolve the intracellular alterations induced by secretion, increase protein synthesis to continue to meet these demands, and resolve the signaling events activated by the previous pulse to allow full response to the next. We have identified the UPR and control of translation as central elements maintaining gonadotrope sensitivity to GnRH and biosynthetic capacity. We propose to examine these components in vitro to determine their mechanism of regulation and in experimental mouse models to determine their physiological role in reproduction. The UPR may provide a direct link between physiological stress and reproductive function. Specific Aim 1: The Unfolded Protein Response in gonadotrope function. We will determine the role of the three main regulators of the unfolded protein response, EIF2AK3 and ERN1, in normal gonadotrope cell function Specific Aim 2: Mechanisms of mRNA redistribution in response to GnRH We have demonstrated that GnRH causes a redistribution of mRNA in gonadotropes. We will determine the specificity of redistribution and the factors determining susceptibility to redistribution. Specific Aim 3: Physiological consequences of an impaired stress response in mice We will examine the role of the unfolded protein response in normal gonadotrope cell function by examining the reproductive impact of pituitary-specific knockout of critical UPR regulatory factors.

Public health relevance
PUBLIC HEALTH RELEVANCE: To preserve normal reproductive hormone production and to respond correctly to environmental cues, pituitary cells must minimize cellular stress and adapt to the demand of continued hormone production. We are investigating the mechanisms cells use to adapt to stress and preserve normal cell function. These regulatory pathways are essential to assure proper reproductive hormone synthesis and reproductive success. Narrative To preserve normal reproductive hormone production and to respond correctly to environmental cues, pituitary cells must minimize cellular stress and adapt to the demand of continued hormone production. We are investigating the mechanisms cells use to adapt to stress and preserve normal cell function. These regulatory pathways are essential to assure proper reproductive hormone synthesis and reproductive success. __SpecificAimsTextDelimiter__ Specific Aims As the mediator of central nervous system control of reproduction in vertebrates, gonadotropin-releasing hormone I (GnRH) is the primary regulator of reproductive function. GnRH stimulates the anterior pituitary gonadotropes which produce the gonadotropins luteinizing hormone (LH) and follicle-stimulating hormone (FSH). Regulation of the glycoproteins is most pronounced on the day of ovulation, which is preceded by rapid frequency and amplitude changes in GnRH stimulation from the hypothalamus, and is attended by similar increases in LH production and release. We have described novel features of GnRH signaling that contribute to the regulation of gonadotropin synthesis. These include differential control of transcription feedback regulators, regulation of translation, and induction of the unfolded protein response (also integrated stress response), a signaling network that controls the response to stress. Re-establishment of homeostasis after a pulse is critical for maintaining sensitivity to pulsatile GnRH. The long-term management of stress is essential to preserve cell and reproductive function. Loss of stress signaling in other systems results in short term increases in protein synthesis followed by decline in synthesis or cell death. In this proposal, our aims are structured upon our desire to understand the stress response to GnRH and the mechanisms resolving it. We will accomplish this by targeting two areas of post-transcriptional regulation of gene expression: the role of the unfolded protein response in gonadotrope function and the mechanisms of mRNA redistribution in response to GnRH stimulation. We will further address the role of the unfolded protein response factors in reproduction using novel conditional knockout mouse models. 1. Aim 1: The unfolded protein response in gonadotrope function GnRH invokes the unfolded protein response, or UPR. The major factors mediating the UPR are EIF2AK3 and XBP1. We will examine their role in maintaining gonadotrope homeostasis. a) EIF2AK3 and the stress response in gonadotropes Stress signals in the endoplasmic reticulum (ER) activate the kinase EIF2AK3 which inhibits translation initiation. We will test the necessity and sufficiency of EIF2AK3 for translational pausing induced by GnRH. b) XBP1 and the stress response in gonadotropes In response to ER stress, ERN1 activates transcription factor Xbp1 mRNA, activating its expression. XBP1 targets regulate cell growth and the decision to activate apoptosis. We will examine the role of XBP1 in GnRH- induced gene expression. 2. Aim 2: Mechanisms of mRNA redistribution in response to GnRH We have demonstrated that GnRH causes a redistribution of mRNA in gonadotropes. We will determine the specificity of redistribution and the factors determining susceptibility to redistribution. a) Determinants of mRNA redistribution to polyribosomes in response to GnRH GnRH causes redistribution of specific mRNAs to polyribosomes. We will determine the mechanism by examining the RNA-binding factors participating in translational control. b) Determinants of mRNA redistribution to ribonucleoprotein complexes in response to GnRH GnRH induces translational pausing of specific mRNAs. We will determine the mechanism by examining mRNA and protein targets of pausing and determine the structural basis for inhibition. 3. Aim 3: Physiological consequences of an impaired stress response in mice We will examine the role of the unfolded protein response in normal gonadotrope cell function by examining the reproductive impact of pituitary-specific knockout of critical UPR regulatory factors. a) Effects of conditional Eif2ak3 knockout on reproduction Loss of the Eif2ak3 gene may lead to short-term increase in gonadotropin production followed by a decline caused by unresolved stress signaling in the gonadotrope. We will examine the effect of EIF2AK3 loss on reproduction in a pituitary-specific conditional knockout mouse. b) Effects of conditional Xbp1 knockout on reproduction Pituitary-specific knockout of the Xpb1 gene may inhibit gonadotropin production by limitation of ER proliferation and capacity, eventually leading to cell death. We will monitor the effects of conditional knockout of Xpb1 in the pituitary under normal and high fat diet conditions to assess the impact on reproduction. .